Quantifying the Race for the Surface via IV-MLSM

Abstract
Implant-associated infections are the bane of musculoskeletal tissue engineering. With over 1.5 million total
hip and total knee replacement procedures performed each year, bone infection primarily caused by
Staphylococcus aureus remains among the most severe and devastating risks associated with musculoskeletal
implants. It has been understood for decades that the addition of a foreign material to a biological environment
provides a haven for bacterial attachment, colonization and recalcitrant biofilm formation. Based on this
dogma, the concept of the “race for the surface” has been established to explains the competition between
host cells and bacteria for implant colonization. To bias this competition in favor of the host, various
antimicrobial biomaterials, surface coatings, drugs and immunotherapies have been tested. While many have
shown promise based on in vitro findings and preliminary results in animal models, none have proven efficacy
in clinical trials. While there are several explanations for the lack of clinical translation, a broadly accepted
shortcoming has been the over reliance on assays (e.g. static biofilm, colony formation units (CFU), minimum
inhibitory concentration (MIC)), and cross-sectional outcomes (e.g. static radiology and microscopy), which
cannot faithfully assess the in vivo infection process. Thus, the Scientific Premise of this program is that real
time in vivo quantification of planktonic bacterial growth on the surface of musculoskeletal implants, and the
innate host response to these bacteria, is critical for the evaluation of novel prophylactic and therapeutic
interventions that significantly inhibit colonization and biofilm formation. To this end, we have pioneered the
use of intravital multiphoton laser scanning microscopy (IV-MLSM) with a murine model of implant-associated
osteomyelitis. Our preliminary studies quantifying the proliferation and surface coverage of red fluorescent S.
aureus, versus surface coverage of green fluorescent host cells on a metal implant within the femur
demonstrate that the race for the surface is very dynamic and complete within 3hrs. In Aim 1 of this program,
we will confirm these findings, and formally establish the real time kinetics of the race of the surface on
standard of care stainless steel implants, and the efficacy of standard of care parenteral antibiotics against
methicillin sensitive and resistant strains of S. aureus. We will also assess cerulean S. aureus in
Ly6GCre/ROSAtdTomato/Csf1r-EGFP mice to quantify implant surface colonization, and clearance of bacteria
(blue) by neutrophils (orange) and macrophages (green) in vivo. In Aim 2, we will test the hypothesis that the
efficacy of previously described antimicrobial implants (“as fired” silicon nitride (Si3N4) and 3D-printed titanium)
is due to their ability to favor host cells over bacterial colonization during the race for the surface. At the
completion of this high risk-high reward program, we will have new in vivo outcome metrics to elucidate the
molecular and cellular mechanisms that govern the race for the surface, and empirical threshold values to
assess the efficacy of antimicrobial interventions for musculoskeletal tissue engineering.

Public health relevance
Narrative Bone infection, primarily caused by Staphylococcus aureus, remains among the most severe and devastating risks associated with musculoskeletal tissue engineering. To facilitate development of antimicrobial implants and treatments that inhibit these bone infections, we propose to establish a mouse model in which this infection process can be imaged in real time with in vivo fluorescent microscopy.